Early Intervention for Postpartum PTSD: Comparing Written Exposure and Capnometry-Guided Breathing Therapy

PROJECT SUMMARY
While childbirth is often viewed as a positive life event, up to one-third of women in the United States describe
childbirth as traumatic. For those who experience severe maternal morbidity (SMM) or whose infants require
neonatal intensive care unit (NICU) admission, the risk of traumatic childbirth developing into postpartum post-
traumatic stress disorder (PTSD) is especially high, with prevalence estimates ranging from 16–20%.
Postpartum PTSD is associated with significant adverse outcomes, including impaired maternal functioning,
disrupted maternal-infant bonding, breastfeeding challenges, and long-term mental health morbidity. Despite
growing awareness of these impacts, postpartum PTSD lacks standardized screening protocols and evidence-
based early interventions that are scalable and suitable for busy perinatal care settings. This multi-site pilot
study will assess the feasibility and acceptability of two innovative, low-burden, early interventions for
postpartum PTSD: Written Exposure Therapy (WET) and Capnometry Guided Respiratory Intervention (CGRI).
WET is a brief, 5-session trauma-focused psychosocial intervention using expressive writing, which has
demonstrated non-inferiority to more intensive PTSD therapies. CGRI is an FDA-approved, home-based,
digital breathing intervention designed to regulate physiological stress responses without requiring patients to
process trauma content—an advantage for postpartum individuals who may prefer non-verbal, body-based
therapies. Both interventions have shown efficacy in other populations but have not been tested in postpartum
contexts. The study includes an initial adaptation and case series phase (n=10), followed by a randomized
feasibility trial (n=60) in postpartum patients with clinically significant PTSD symptoms (PCL-5 score ≥28)
within one month of a traumatic childbirth event. Participants will be randomized to WET, CGRI, or standard
routine follow-up by nursing or social work (n=20 per group). Primary outcomes include feasibility of
recruitment, intervention fidelity, patient adherence, and intervention acceptability using both quantitative
measures and qualitative interviews. Secondary clinical outcomes include changes in PTSD symptom severity
at 6 weeks and 3 months, as well as validated measures of maternal depression, anxiety, bonding,
breastfeeding, and functional recovery. A novel exploratory aim will also assess the feasibility of collecting
maternal hair samples during hospitalization and postpartum follow-up to measure a panel of corticosteroids
(e.g., cortisol, cortisone, progesterone) using liquid chromatography-tandem mass spectrometry. These
biomarkers will be evaluated in relation to PTSD symptom severity and treatment response, with the goal of
informing future precision mental health strategies. This study will generate essential data to guide the
development of a fully powered randomized controlled trial and support scalable, accessible early interventions
for postpartum PTSD. This project aims to reduce suffering and enhance postpartum recovery outcomes in
alignment with the NICHD’s mission to prevent maternal mental health disorders and promote lifelong health.

Public health relevance
Project Narrative One-third of individuals experience traumatic childbirth, which is associated with a three-fold increased risk of post-traumatic stress disorder (PTSD) one-year postpartum; a condition which can negatively affect both maternal and infant health. This study will test two simple, low-burden, remote therapies (written exposure therapy and a digital breathing therapeutic) designed to prevent PTSD within the first 5 weeks after a potentially traumatic childbirth, and will also explore whether hair corticosteroid levels can be used to detect biological signs of stress and recovery.